Defining the impact of interpersonal gut microbiota variation on oral cholera vaccine responsiveness

PROJECT SUMMARY
The human pathogen Vibrio cholerae causes cholera, a severe human diarrheal disease that affects millions of
people annually. A number of oral cholera vaccines (OVC) have been developed but show varying efficacy
among populations in distinct geographical regions, with poor OCV response being common in cholera
endemic areas. However, the underlying causes of this variation are poorly defined. There is therefore an
unmet global health need to develop strategies that boost the effectiveness of these lifesaving OCVs. The
resident microbial community of the gastrointestinal tract, the gut microbiome, varies significantly among
individuals, and this variation has been linked to variation in host phenotypes and responses to therapeutics.
Our central hypothesis is that inter-individual variation in the microbial populations of the gut contributes to the
high level of geographical variation in OCV efficacy through effects on the intestinal immune system. Our
preliminary data shows that the gut microbiome represents a personalized contributor to OCV outcome; (i)
specific gut bacterial taxa correlate with high and low responsiveness to OCV, inter-individual microbiota
variation in cholera endemic areas (ii) directly impact infection outcome and immune responses to V. cholerae
and (iii) recapitulates human donor OCV outcomes in a germfree mouse transplantation model, and (iv) gut
microbiome modulation of host CD4+ T cells critically regulates immune responses to V. cholerae. Precision
editing of the gut microbiome therefore represents an attractive strategy to boost OCV responsiveness, but
implementation of such approaches requires detailed understanding of the specific microbes responsible, and
the nature of their interactions with the host immune system. We will leverage our team’s expertise in OCV
clinical studies, metagenomics, anaerobic microbiology, intestinal immunology, and gnotobiotic mouse models
to make causal and mechanistic links between structural variation in the gut microbiome and human vaccine
responsiveness, and to identify specific microbes able to drive strong OCV outcomes. Our ultimate goal is to
identify specific microbial taxa that drive divergent immune responses to V. cholerae, which may then inform
microbiome-targeted probiotic and prebiotic strategies for cholera prophylaxis. We will address this problem
through the following Specific Aims: Aim 1- Determine the effect of inter-individual microbiota variation on OCV
responsiveness; Aim 2- Define the microbiota targets that enhance responsiveness to oral cholera vaccines;
Aim 3- Define the immune cell populations that mediate microbiota-driven effects on OCV.

Public health relevance
PROJECT NARRATIVE The pathogenic bacterium Vibrio cholerae causes cholera, a devastating diarrheal disease that affects millions of people worldwide each year. Several life-saving oral cholera vaccines (OCV) have been developed, but they show varying efficacy in different geographical regions and from individual to individual. The proposed studies will identify how differences in the composition of the native microbial community of the gut, the gut microbiome, contributes to differences in response to oral cholera vaccines, and identify candidate next- generation probiotic and prebiotic approaches targeting the gut microbiome to improve strategies for cholera prevention.